Chemical Synthesis Shared Resource

CHEMICAL SYNTHESIS SHARED RESOURCE - PROJECT SUMMARY/ABSTRACT
The Chemical Synthesis Shared Resource (CSSR) enables novel chemical synthesis to MECCC researchers who do not have the facility to create novel molecules in their own laboratories. In this role, the CSSR offers a broad spectrum of chemical synthesis, medicinal chemistry, computational chemistry, analytical chemistry, chemical reactivity and chemical identification services for unknowns. CSSR provides consulting and project planning with a particular focus on project planning for research grant applications. Data evaluation for the use of CSSR compounds, editing and publishing support is provided as part of the service to members of the MECCC. CSSR is equipped with state-of-the-art instrumentation to perform complex chemical reactions including, low temperature, photochemical, chiral synthesis, organometallics, carbohydrates, peptides, pressure reactions, isotopic labeling, and microwave-stimulated chemistry. CSSR services in chemical synthesis are custom-tailored to solutions for each MECCC investigator. From simple reagent synthesis of a reference compound to collaboration throughout an entire project, CSSR provides chemical validation from the grant application to the published work. All chemical needs and problems are addressed on the level of the individual investigator. The specific aims are as follows:

1. Provide high quality chemical synthesis expertise to MECCC researchers by planned interactions between MECCC investigators and resource personnel.
2. Provide expert project-related chemistry for grant and proposals and publications.
3. Develop and expand ligand screening capacity for novel targets of the MECCC research community. Curate and expand, as needed, the click-chemistry (Copper catalyzed azide-alkyne cycloaddition, SuFEx) library within the CSSR for use in novel cancer targets. Develop screening protocols and reagents for applying the new technology of SuFEx targeting discovery. Incorporate computational virtual screening as leads to new chemical compound synthetic targets within the CSSR.

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward CHEMICAL SYNTHESIS SHARED RESOURCE - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page